METHODS AND ANALYSIS CORE

Project Summary/Abstract
Unhealthy alcohol use is a major unaddressed barrier to control of the HIV epidemic in sub-Saharan Africa and
the United States. The Zambia Alabama HIV Alcohol Comorbidities (ZAMBAMA) program aims to address this
barrier through the following overarching aims: (a) test the effectiveness of a transdiagnostic model (Common
Elements Treatment Approach [CETA]) to reduce unhealthy alcohol use and improve HIV clinical outcomes; (b)
evaluate the mechanisms through which CETA impacts HIV outcomes; (c) investigate whether the treatment
effect of CETA varies by clinical (e.g., presence of mental health comorbidities), demographic (e.g., gender) and
contextual (e.g., Zambia, Alabama) factors; and (d) examine implementation factors, including cost, related to
integrated delivery of alcohol reduction interventions to disadvantaged people with HIV and unhealthy alcohol
use at front-line HIV clinics. The Methods and Analysis Core (MAC) will support ZAMBAMA’s two clinical trials
and promote integration and synergy within the program. The specific aims of MAC are (1) implement the
scientific approach of both trials (e.g., overseeing randomization procedures, measurement tools, and data
management); (2) conduct primary and secondary outcomes analyses evaluating CETA’s effectiveness
(including moderator analyses); (3) conduct mediator/mechanisms analysis investigating the degree to which
CETA’s impact on HIV outcomes are mediated by reductions in alcohol use, substance use, and mental health
problems; (4) analyze and interpret alcohol biomarker (phosphatidylethanol) data used to confirm self-reported
alcohol abstinence data; and (5) analyze implementation and cost effectiveness data to inform the scale-up and
sustainability potential of CETA. MAC will be staffed by investigators with international and multidisciplinary
expertise in research methods, including in substance use, HIV, clinical trials, and global health. MAC will
leverage a wealth of information technology, statistical, and laboratory resources at participating institutions,
including Centre for Infectious Disease Research in Zambia, Columbia University, and the University of Alabama
at Birmingham. Harmonized patient reported outcome measures and a centralized team to oversee the
intervention (i.e., CETA core) for both trials will create unique opportunities to understand the interplay between
unhealthy alcohol use and psychiatric comorbidities, whether and how comorbidities influence alcohol treatment
outcomes, and how differences in delivery modality and contextual factors impact CETA’s effectiveness.

Public health relevance
Project Narrative Unhealthy alcohol use represents an unaddressed barrier to achieving and maintaining control of the HIV epidemic both in sub-Saharan Africa and in the rural United States. The Zambia Alabama HIV Alcohol Comorbidities (ZAMBAMA) program will test the effectiveness of two interventions, a brief alcohol intervention (BI) and a transdiagnostic cognitive behavioral therapy-based model called Common Elements Treatment Approach (CETA), in reducing unhealthy alcohol use and mental health comorbidities and in improving HIV outcomes among persons living with HIV in Zambia and Alabama. The Methods and Analysis Core (MAC) will support ZAMBAMA by providing expertise in data collection, management, and analyses within the CHARTZ (CETA HIV Alcohol Reduction Trial in Zambia) and TALC (Telemedicine for unhealthy Alcohol use with CETA) clinical trials, and by leveraging integrated approaches across the trials to create synergistic analyses within the P01 program.